Preventing Prescription Stimulant Diversion and Medication Misuse Via a Web-Based Simulation Intervention

PROJECT SUMMARY
College students misuse and divert (i.e., give away, sell, or trade) prescription stimulants more often than any
other class of prescription drugs (e.g., opiates). Half or nearly half of college students with prescriptions divert
their stimulant medication, and a similarly high percentage misuse their medication (e.g., higher doses, via
different routes of administration, etc.) or use someone else’s prescription. Diversion may lead students to go
without needed medication to mitigate their symptoms, increasing their risk for unintentional injuries and
substance use. Further, diversion perpetuates the non-medical use of prescription stimulants (NMUPS), which
has become increasingly common among college students and is associated with other illicit drug use, lower
grade point average, insomnia, irritability, headaches, and cardiovascular complications. Diversion also
perpetuates medical misuse of stimulants among students with prescriptions, which is associated with poorer
ADHD symptom management and may increase the risk for addictive disorders. Despite the fact that nearly
9 out of 10 students obtain prescription stimulants from a friend or acquaintance with a prescription,
there are no evidence-based interventions targeting diversion of stimulants in college students. Being
approached for one’s medication is a key risk factor for diversion, as is medication non-adherence and
believing NMUPS and diversion are more prevalent than they are. Accordingly, in this multi-site study, we will
conduct a randomized, controlled trial of 300 college-attending adults with current stimulant prescriptions to
examine the preliminary efficacy and feasibility of a single-session, computer-based simulation intervention
(with two booster sessions) to prevent prescription stimulant diversion and medication misuse and compare it
to a placebo condition. Our intervention, which is grounded in social learning theory, the theory of planned
behavior, and our preliminary research, uniquely engages students in interactive discussions with virtual
humans to (a) learn about the actual prevalence of NMUPS and diversion and their related risks, (b) practice
using refusal strategies when approached for their medication in high-risk situations, and (c) understand how to
effectively communicate with prescribers and avoid medication misuse. Our primary aims are to determine if
the intervention reduces diversion, intentions to divert, and medication misuse, and to assess user satisfaction
with the intervention. Our secondary aims are to examine change in potential mechanisms of action targeted in
the intervention, such as self-efficacy to resist diversion, knowledge about diversion and NMUPS, use of
behavioral strategies to resist requests for one’s medication, and prescriber communication. Our study
responds to PA-17-775, which calls for pilot testing of innovative technology for disseminating effective
preventive interventions. It also aligns with NIDA’s Strategic Plan, which encourages the development of
preventive interventions that target risk factors for substance use disorders. If effective, the intervention could
be readily and widely disseminated to college counseling centers, psychiatrists/APRNs, and pediatricians.

Public health relevance
PROJECT NARRATIVE Prescription stimulants are diverted (given, sold, or traded) and misused on college campuses more than any other class of prescription drugs, leading to negative physiological and psychological outcomes for both prescribed and non-prescribed students. Given that there are no evidence-based preventive interventions for diversion and the misuse of one’s prescription, we are using a randomized, controlled trial to test an interactive computer-based simulation that coaches students on how to resist peers’ requests for medication and encourages medication adherence and communication with their prescriber. This pilot research is a critical first step in the development of a low-cost, time efficient, developmentally appropriate intervention for diversion and medication misuse that can be disseminated to practitioners and student support personnel in healthcare and college settings, with the eventual goals of reducing psychological morbidity and other substance use in prescribed students and prescription stimulant misuse in non-prescribed students.